Altered innate leukocyte programming dynamics in sepsis

PROJECT SUMMARY
Sepsis poses grave health concerns with no effective prevention or cure. The key stumbling block is the
highly complex nature of the disrupted innate leukocyte homeostasis. Disrupted sepsis monocyte homeostasis
is reflected in a dramatic early upswing of inflammatory processes followed by a late-phase compensatory
tolerance. Disrupted neutrophil homeostasis in sepsis patients is cardinally represented by “migratory paralysis”
in which septic neutrophils lose migratory potential toward bacterial products while retaining migration toward
sterile tissues, due to preferential reduction of FPR2 and induction of CCR5. Septic neutrophils also have
reduced potential for generating neutrophil extra-cellular trap (NET). Collectively, these disrupted innate
leukocyte homeostasis may compromise host defense and exacerbate multi-organ inflammation. However,
mechanisms underlying monocyte priming and neutrophil paralysis are poorly understood. Due to their highly
dynamic natures, current experimental systems in vitro or animal models in vivo fail to properly capture the
disrupted leukocyte homeostasis. The PI’s past systems analyses with experimental and computational
approaches reveal a model system that recapitulates the disrupted human leukocyte homeostasis in vitro and in
vivo by applying subclinical super-low dose lipopolysaccharide (LPS). In sharp contrast to the effects of widely
used higher dosages LPS which preferentially facilitate monocyte tolerance, Dr. Li’s lab documented that super-
low dose LPS “primes” monocytes for prolonged “run-away” inflammation. In addition, Li lab observed that super-
low dose LPS “programs” neutrophils into a paralytic state, mimicking septic neutrophils with reduced FPR2,
reduced potential of bacterial killing and elevated CCR5. Monocyte priming and neutrophil paralysis by super-
low dose LPS can be observed in human blood leukocyte ex vivo. With the cecal ligation and puncture sepsis
model, Li lab demonstrated exacerbated sepsis mortality in mice pre-conditioned with super-low dose LPS.
Mechanistically, Li lab observed that super-low dose LPS potently reprograms monocytes and neutrophils by
disrupting key homeostatic events and molecules. Based on these intriguing observations, the long-term goal
is to understand the disrupted innate immune dynamics responsible for the elevated morbidity and mortality of
sepsis. As a crucial first step, our key objective is to better understand the mechanisms responsible for the
disrupted homeostasis in monocytes and neutrophils. This project plans to test the central hypothesis that
monocyte priming and neutrophil paralysis during sepsis are caused by the disruption of key homeostatic
molecules and processes. Aim 1 will test the hypothesis that the disruption of homeostatic molecules such as
RelB is responsible for the monocyte priming conducive for increased sepsis mortality. Aim 2 will reveal the
fundamental cellular and molecular mechanisms responsible for neutrophil paralysis. Aim 3 will test whether that
alteration of leukocyte dynamics may exacerbate, while restoration of leukocyte homeostasis may attenuate
sepsis pathogenesis.

Public health relevance
PROJECT NARRATIVE The goal of this project is to characterize novel mechanisms underlying the disrupted homeostasis of innate monocytes and neutrophils, as well as a novel strategy to modulate innate leukocyte homeostasis.